Modeling immune impairments and pathogenesis in novel humanized mice for HBV-HIV co-infection

Project Summary
Co-infection with HBV and HIV-1 is common, and HIV co-infection can exacerbate progression of viral hepatitis
and accelerate liver disease progression. A major hurdle to elucidating potential mechanisms underlying these
common and serious diseases, and thus to developing effective therapies, is the lack of small animal models that
reproduce human-like infection with HBV and HIV-1. Both viruses exhibit a narrow host range in which infection is
largely limited to humans and other great apes. Our labs (Ploss and Su) have developed novel humanized mice
that are co-engrafted with human livers and human immune cells (FNRGF/A2-hu HEP/HSC mice), with human
hepatocytes and improved human myeloid cell/DC and NK cell subsets that are underrepresented in conventional
humanized mouse models. We have demonstrated that these refinements yield vaccine-induced immunogenicity
profiles resembling those of humans who have been vaccinated with the same well-defined YFV-17D vaccine. We
will capitalize on these promising breakthroughs to investigate the following: 1) We will infect cohorts of FNRGF/A2-
hu mice dually engrafted with human HLA-matched hepatocytes and human hematopoietic cells with HBV and/or
HIV-1. We will monitor, and quantify longitudinally, HBV and HIV viremia and immune activation, including antigen-
specific CD8+ T cells and liver disease progression (Aim 1A). We will also perform analyses in cohorts of HBV/HIV
co-infected mice which have been treated with HAART (including HBV polymerase inhibitors), to suppress HIV-1
and HBV, to model accurately clinically relevant situations (Aim 1B). 2) We will study HIV/HBV-induced T cell
impairment. We will monitor T cell exhaustion markers on HIV and HBV specific T cells and profile functional
impairments in antigen specific CD8+ T cells during HBV/HIV co-infections using single-cell transcriptomics (Aim
2A). We will also evaluate the impact of blocking INFAR1 on HIV/HBV-induced immune impairment. We will monitor
reversion of T cell exhaustion functions of HIV- and HBV-specific T cells and profile IFN-induced functional
impairments in antigen specific CD8+ T cells during HBV/HIV co-infections (Aim 2B). 3) We will investigate how
HIV-1 infection elevates HBV-induced pathogenic macrophages in the liver of humanized mice in vivo (Aim 3A).
We will also study how HIV and HBV interact with M2-like macrophages to activate human stellate cells (Aim 3B).
Finally, we will study how inhibiting M2-like macrophages prevents or reverses HIV/HBV-induced liver diseases in
humanized mice (Aim 3C).
We will thus capitalize on our extensive complimentary expertise in virology and immunology of HIV-1/HBV (Su),
hepatitis viruses (Ploss) and in humanized mouse technology to achieve the exciting aims. Our work will advance
the field of HBV and HIV-1 research by showing that a novel small animal model can be successfully used to
understand HIV/HBV coinfection and immune responses, and to model treatments for the associated liver diseases.

Public health relevance
Public Health - Project Narrative Our proposed work will use a cutting-edge humanized mouse model to advance understanding of the relationship between HBV/HIV coinfection and liver disease. The model relies on mice engrafted with both human liver and human immune cells to support coinfection of HBV and HIV-1 and mount human-like immune responses to these two pathogens.